Bridging the Gap: Using Foreign Real-World Data to Inform Interchangeable Biosimilar Approvals

PROJECT SUMMARY/ABSTRACT
This study will use real-world data (RWD) from the U.S., Italy, and Denmark to evaluate
alternative approaches to meet the standard for interchangeable products (Area 2.ii.). The long-
term objective is to develop recommendations for the FDA on using foreign RWD to improve
regulatory processes. The study will determine the potential of RWD from outside the U.S. to
improve the power and generalizability of U.S. regulatory studies. Researchers will use an
observational/non-interventional retrospective cohort design to address two specific aims with
the following methods:
• Aim 1: Evaluate the feasibility and validity of a biosimilar interchangeability (e.g.
switching) study using real-world data from the U.S. and sources from outside the
U.S. The study will evaluate the quality of RWD from two foreign sources and develop a
common data model to harmonize the data. The Principal Investigator (PI) will design a
shared protocol. Co-Investigators will conduct emulations of a switching study of a biosimilar
product at U.S., Italian, and Danish sites. The PI will compare the results at each site and
compare the results with an existing study to validate our findings.
• Aim 2: Develop recommendations for the FDA on how to address the challenges
of using real-world data from outside the United States in its regulatory decision-
making processes. Based on learnings from Aim 1, the PI will propose guidance for the
FDA to consider. The guidance will recommend strategies to address the unique challenges
associated with collecting, standardizing, and validating RWD from international sources.
This study will show how using foreign RWD can significantly improve the efficiency of the FDA
regulatory process, leading to increased adoption of safe and effective biosimilar products. This
innovative approach could also serve as a model for using RWD from outside the U.S. in
regulatory decision-making across different therapeutic areas. This study will help the FDA
advance its mission of making safe and effective drugs available to patients.

Public health relevance
PROJECT NARRATIVE The slow and complex approval process for biosimilar products hinders patient access to less expensive biologic therapies. Our proposed multinational study, "Bridging the Gap: Using Foreign Real-World Data to Inform Interchangeable Biosimilar Approvals," aims to identify opportunities and challenges in using foreign data to accelerate the biosimilars approval process. Our findings will inform the FDA's efforts to streamline the evaluation of new interchangeable biosimilar products and make safe and effective biosimilars available to patients more quickly.